Propagation of Light in Tissue and Imaging

A theoretical model of light propagation in tissue, which accounts for scattering and absorption of light, predicts the spatial profile of the surface intensity of re-emitted light. The model allows for both re-emission of the introduced light and fluorescent light generated by an embedded chromophore either inherent to or introduced in the tissue. Measurement of a series of surface intensity profiles allows reconstruction of the three-dimensional structure of the tissue using inverse analytical techniques. Prototype instrumentation has been developed to capture surface images for analysis. A laser scanning system introduces light into the tissue at a series of sites in the region of interest and the emitted light is optically filtered through a dichroic filter and imaged on to a cooled charge coupled detector. Measurements using this instrumentation of fluorescent markers embedded in a highly scattering turbid medium yielded excellent agreement between the reconstructed theoretical prediction and the experimental measurement of these known sites. The techniques are being developed as non-invasive methods to diagnose diseased salivary glands in Sjorgen's syndrome and to identify sentinel nodes for biopsy in breast cancer. Identification of deeper structures within the tissue is possible by extending the instrumentation to capture images in the near infra-red region of the spectrum and by the use of novel infra-red compounds to act as probes localized at desired sites within the tissue. DBEPS, in collaboration with NCI and NICHD, has explored the use of nanocrystals as an angiographic contrast agent. These nanocrystals, obtained from Nomadics, Inc., have semiconductor cores (CdMnHgTe) approximately 5 nm in diameter, and are coated with bovine serum albumin (BSA). The size and composition of these particles cause them to fluoresce in the near-infrared (NIR), the spectral range in which the absorbance of water as well as most tissue chromophores is lowest. By injecting small amounts of nanocrystals intravenously into mice, we have demonstrated the ability to use the CdTeMnHg-BSA nanocrystals as a non-toxic, fluorescent, angiographic contrast agent in the NIR range. Blood vessels on the order of about 100 micometers in diameter, located at a depth of 1-2 mm in tissues consisting of skin, fat, and/or bone have been visualized. There was no significant photobleaching or degradation of the nanocrystals over the time scale for any of the phantom or in vivo experiments. The use of polarized light has been explored in conjunction with NICHD and NCI as a method to track changes in tissue structure. Polarized photography offers the potential of distinguishing hidden structures developed below the skin surface such as fibrosis resulting from X-ray radiation. A variable angle polarized illumination system directed laser light on the surface of the skin of an athymic mouse. The scattered light (captured at an angle to minimize directly reflected light) was analyzed using a polarization sensitive detector for changes in polarization resulting from the interaction of the light and the tissue. Clear differences were observed for the degree of polarization between the skin of normal athymic mice and mice irradiated with X-rays.